Mays Cancer Center at UT Health SA

Project Summary--Population Science and Prevention (PSP) Program
The Population Science and Prevention (PSP) Program, co-led by Pratap Kumar, Ph.D. and Gail Tomlinson,
M.D., Ph.D., has 29 members, representing 4 schools and 10 departments at the Mays Cancer Center (MCC)
at the University of Texas Health San Antonio (UT Health SA). The primary focus of the PSP Program is
collaborative research that addresses cancer risk and prevention to develop intervention strategies. Studies are
focused on our overarching goal of reducing cancer burden in our 38-county catchment area. Our emphasis has
been on improving cancer screening and detection, improving access to care, and translation prevention
discoveries through interventional trials. These include behavioral interventions to improve cancer outcomes,
incorporating community outreach and engagement of underserved populations. PSP members have: 1)
Formulated a panel of patented biomarkers for predicting recurrent risk of prostate cancer; 2) Identified
epigenotypes for stratifying an endometrial cancer subtype predominantly occurring in young, obese Hispanics;
and 3) Shown that exposure to aflatoxin and hepatitis C virus may cause hepatocellular carcinoma in our
catchment area and other Hispanic populations. Inter- and intra-programmatic efforts have found that: 1) Yoga-
based exercise and nutritional interventions can reduce circulating inflammatory cytokines, thereby enhancing
survival of breast cancer patients; and 2) Texting and mobile media services help Hispanic adolescent/young
adults (AYAs) quit smoking in a cost-effective manner. Through our collaborative work, we have impacted the
population across our geographic area (including rural and border regions): e.g. increased identification rates of
those carrying hepatitis C, and increased HPV vaccine administration, genetic risk assessment and testing, and
enhanced cancer screening in genetically at-risk populations. In the upcoming Cancer Center Support Grant
(CCSG) cycle, we continue to address the disproportionate burden of cancer across the age continuum –
children, AYAs, and adults – in our catchment area. Our Program’s Specific Aims are to: 1) Discover biomarkers
to enhance early detection and recurrent prediction; 2) Translate evidence-based chemotherapeutic/
nutritional/behavioral strategies to interventional trials; and 3) Enhance quality of life for cancer survivors. These
Specific Aims will be achieved by promoting intra- and inter-programmatic collaborations to translate findings
into clinical interventions to benefit our population. PSP Program members hold 28 grants totaling $5.7M (direct
costs), with 25% ($1.4M) from the NCI. Over the last reporting period, the PSP’s multidisciplinary investigators
more than doubled their peer-reviewed publications (412 vs. 186). Of these, 21% are intra-programmatic, 14%
inter-programmatic, 77% multi-institutional collaborations, and 53% with other NCI-designated Cancer Centers.
In addition, 34% of PSP publications during this period were from journals with an impact factor >5. PSP
members led 21 clinical research studies during 2018 and placed 171 patients on interventional studies and 332
on non-interventional studies. PSP members have used all six MCC core facilities, especially the Biostatistics
and Bioinformatics Core. Initiatives are being generated by newly recruited PSP faculty whose skill sets enhance
the Program scope and Specific Aims by cross-cutting translational working groups, and by close collaborations
with the other MCC Programs and the UT Health SA scientific community.